Molecular, Epigenetic and Genomic Approaches to Understand Mechanisms of Aging in the Human Testis

PROJECT SUMMARY ABSTRACT
Due partly to socio-economic reasons, there is a general trend of increased parental age in the industrialized
countries. Advanced parental age is known to be associated with several risk factors including decreased
genome integrity, impaired organ maintenance, increased mutations (which may cause testicular cancer), altered
epigenome in the germline, and reduction in fertility. Importantly, these germline alterations can be transmitted
to the offspring, resulting in higher risks for several diseases/syndromes (e.g. Achondroplasia, Apert, Noonan
and Costello) in their children. However, the detailed molecular mechanism underlying human testis aging is
highly understudied. Prior work on human germline and niche has involved physiological approaches, but has
not revealed the detailed molecular and genomic drivers of germline development, or which aspects deteriorate
during aging. The recent advent of powerful single-cell genomics approaches allows us to examine gene
expression, chromatin and DNA methylation (DNAme) genome-wide, and offer major new opportunities for a
molecular and mechanistic understanding of the impact of aging on both germline and somatic niche cells. In
this proposal, by utilizing a combination of single cell genomics, molecular and cell biology approaches, we aim
to gain a mechanistic understanding of how human germline ages in respond to the aging niche, and how this is
related to individuals’ health and that of their offspring. Our prior studies established many principles of germline
transcription-epigenetic relationships and inheritance, provided the first single-cell analyses of pubertal and adult
testes, and described the first age-dependent changes in sperm DNAme. This project aims to greatly extend our
prior work, by utilizing our robust testis acquisition pipeline (66 pairs of whole testes preserved with ongoing
acquisition) to examine thousands of germline and niche cells from young adults through men of advanced age,
to test the following Hypothesis: The transcription, open chromatin and DNAme status of human male
germline (spermatogonia and developing gametes) changes during aging, and responds to changes in
the aging niche. Specifically, we will utilize single cell genomics techniques to examine the transcription, open
chromatin and DNAme profiles of testicular cells from age stratified males (20-29, 30-39 etc). We aim to
understand the impact of aging on the germline (AIM 1) and somatic niche cells (AIM 2). Importantly, we will
also apply functional experiments including spermatogonia xenotransplantation and in vitro organoid culturing,
aiming to test the developmental potential of germline or testicular niche cells. Furthermore, as BMI (body mass
index) often increases with age, we will also assess the correlations of observed changes with BMI, as we have
sufficient samples to stratify each age range by high and low BMI. Taken together, by identifying potential drivers
for human testis aging, we aim to transform the management of age-associated pathology (e.g. infertility and
cancer) and gain a deep molecular understanding of the diseases/disorders caused by advanced paternal age.

Public health relevance
PROJECT NARRATIVE/REVELANCE TO PUBLIC HEALTH This proposal aims to delineate the molecular mechanism underlying human testis aging through a combination of single-cell genomics, molecular and cell biology approaches. Recent data has demonstrated multiple degenerative changes in human reproductive tissues during aging, which can also be transmitted to the offspring and cause inherited disorders. Therefore, defining and understanding the molecular drivers of human testis aging has great implications for human reproductive health and wellness of the offspring.